Mechanistic insights into lipid A modification by the phosphoethanolamine transferase MCR-1

Project Summary
Phosphoethanolamine (PEA) transferases are bacterial inner membrane proteins that catalyze the addition of
PEA from phosphatidylethanolamine (PE) donor substrate to the 1- or 4’-phosphate groups of lipid A, as a result
conferring resistance to a class of last-resort, positively charged antibiotic drugs known as polymyxins.
Polymyxins treat multidrug-resistant Gram-negative bacterial infections by electrostatically interacting with the
anionic lipid A anchor of lipopolysaccharide (LPS) molecules on the outer membrane (OM), in turn disrupting the
membrane and leading to cell death. Hence, by cleaving and adding cationic PEA from PE to lipid A, PEA
transferases reduce the overall negative charge on the OM and interfere with the ability of polymyxins to interact
with lipid A. While most of these enzymes – including the lipid A PEA transferase (EptA) – are chromosomally
encoded, the recent discovery of the first variant of mobilized colistin resistance (MCR-1) on plasmids in China
entails that, for the first time, bacteria are capable of using horizontal transfer to confer plasmid-mediated
polymyxin resistance between different strains, thus constituting a significant additional public health risk. Indeed,
the mcr-1 gene has already been reported worldwide in livestock, food, and humans, underscoring the need to
better understand the molecular mechanism by which PEA transferases generally and MCR-1 specifically modify
lipid A to confer polymyxin resistance. The recently reported crystal structure of EptA from Neisseria meningitidis
(NmEptA) has shown that PEA transferases exist as monomers comprised of distinct C-terminal soluble and N-
terminal transmembrane (TM) domains with five TM helices. The presence of a small cavity in the NmEptA
crystal structure harboring residues conserved among PEA transferases, and the absence of an obvious
additional binding cavity, suggests that these enzymes may bind PE and lipid A sequentially, whereby a major
conformational change between the soluble and TM domains enables the larger lipid A to bind in the same cavity
as PE. However, the lack of a full-length, substrate (either PE, lipid A, or both)-bound structure in a native-like
lipidic environment precludes a full understanding of this molecular mechanism. I hypothesize that such a
structure would be able to validate the proposed mechanism-of-action and reveal the extent to which residues
in the putative substrate binding cavity or elsewhere play a role in donor (PE) and acceptor (lipid A) substrate
binding as well as coordination of the PEA intermediate. To address these questions, I will utilize structural and
functional analyses of full-length MCR-1 in lipid-filled nanodiscs by single-particle cryo-electron microscopy
(cryo-EM) in addition to well-established lipid A modification and polymyxin-resistance assays in whole cells.
Two aims are proposed: (1) to determine the structure of substrate-bound MCR-1; and (2) to investigate the
specific interactions of MCR-1 with PE and lipid A. Together, these data will provide molecular-level insight into
the mechanism that MCR-1 uses to bind its substrates and coordinate and transfer PEA to modify lipid A, which
in turn will be critical for drug design efforts to inhibit MCR-1 function and treat polymyxin resistance.

Public health relevance
Project Narrative Phosphoethanolamine (PEA) transferases are integral membrane bacterial enzymes that modify lipid A by PEA attachment, consequently interfering with the ability of polymyxin drugs to electrostatically interact with lipid A and disrupt the outer membrane. The recent discovery of a plasmid-encoded PEA transferase, known as the first variant of mobilized colistin resistance (MCR-1), entails the potentially rapid spread of polymyxin resistance worldwide and between bacterial strains through horizontal gene transfer. This project aims to elucidate the molecular mechanism by which MCR-1 binds its donor substrate, phosphatidylethanolamine (PE), and transfers the positively charged phosphoethanolamine (PEA) intermediate to its negatively charged acceptor substrate, lipid A, on the inner membrane of Gram-negative bacteria, thereby conferring resistance to last-resort antibiotics.